RBC-mediated mopping of cytokines for the treatment of pneumonia

ABSTRACT / SUMMARY
Despite the advent of antibiotics and antivirals, pneumonia remains a major killer. In typical years, it
kills >50,000 Americans, and in the last year, nearly 10x that amount due to COVID-19. The reason for these
deaths is rarely because we cannot stop microbial expansion. Rather, it is due to the host response, in which
local inflammation in the lungs causes a very high concentration of pro-inflammatory cytokines to spill into the
blood, whereupon the cytokines travel to and damage remote organs.
To eliminate excessive cytokines, many antibodies have been developed to bind and neutralize
cytokines. However, these antibodies extravasate into the infected tissue (lungs), where they also inhibit the
beneficial function of these cytokines, which is the orchestration of leukocytes to clear the microbes. To
prevent this problem and the subsequent microbial overgrowth, there is a need to engineer therapeutics that
only quench cytokines in the bloodstream, and not in the infected tissues that rely upon cytokines for microbial
clearance.
To accomplish this, we have developed RBC-Mops. RBC-Mops bind and quench cytokines, but only in
the bloodstream, with no extravasation into infected tissues. We will build and test RBC-Mops across two
Aims: In Aim 1, we will test RBC-Mops ability to bind their targets in vitro, evaluate for damage to RBCs
themselves, and determine the pharmacokinetics and biodistribution of RBC-Mops in naive mice. In Aim 1, we
will test RBC-Mops in the Klebsiella mouse model of pneumonia, evaluating benefits to the lungs and remote
organs, while also investigating potential side effects.
This R21 is designed to produce and validate the prototype RBC-Mop within 2 years. After that, we will
apply for an R01 to further the translational potential of RBC-Mops and better understand their mechanisms.
Eventually, we hope to develop a combination of RBC-Mops that can eliminate cytokines and other circulating
toxins, to ameliorate a large range of acute illnesses, including viral pneumonia (COVID-19), sepsis, and sterile
cytokine release syndromes produced by immunological therapies.

Public health relevance
NARRATIVE Despite antibiotics’ ability to kill bacteria, pneumonia still leads to ~45,000 annual US deaths. These deaths are due to an over-exuberant “host response,” in which inflammatory proteins (cytokines) produced by the patient’s lung cells leak into the systemic circulation and produce inflammatory damage in organs outside the lungs. To combat this problem, we will develop a technology which will bind to and sequester only these circulating cytokines, thereby allowing the immune system and antibiotics to clear the lung infection while preventing host-response-mediated damage to other organs.